Perineuronal proteolysis and circuit dysfunction in HAND

Due to strong excitatory input, reliable GABA release and fast firing, parvalbumin expressing (PV)
neurons are thought to represent critical pacemakers for synchronous network events. PV neurons also
represent the predominant GABAergic neuronal population that is enveloped by the perineuronal net
(PNN), a lattice like extracellular matrix that is thought to localize glutamatergic input. Disruption of the PNN
has been linked to reductions in PV excitability. Importantly, deficits in PV excitability influence
synchronous network events critical to both attention and long-term memory consolidation. In support of
this, recent studies have demonstrated that reduced glutamatergic input to hippocampal PV cells, through
knockout of PV selective glutamate receptors or a reduction in presynaptic glutamatergic innervation, is
linked to increases in sharp wave ripple (SWR) density and deficits in long term memory consolidation.
PNN processing occurs through the actions of specific proteases. While metalloproteinases of the “a
disintegrin and metalloproteinase with thrombospondin motifs” (ADAMTS) and secreted matrix
metalloproteinase (MMP) family members can cleave specific PNN components, the latter may be
particularly important in the background of human immunodeficiency virus (HIV) infection. Soluble MMPs
are expressed by neurons and microglia and known to digest PNN components including aggrecan and
brevican. In addition, while ADAMTS protein expression is not detected in astrocytes in a simian
immunodeficiency virus (SIV) model, PNN degrading MMPs are highly expressed by astrocytes, the most
numerous cell type in the brain. Moreover, in murine models of brain injury, selective MMP inhibition
reduces PNN remodeling.
It has previously been demonstrated that human HIV encoded Tat protein can increase the
expression and/or cellular release of MMP-9, a potent modulator of PNN processing. Tat protein is
detectable in the cerebrospinal fluid of individuals receiving combination anti-retroviral treatment (cART). In
new preliminary data included herein, we show that Tat significantly increases release of MMP-13 from
astrocytes. Moreover, we see active forms of MMP-13 in brain tissue lysates from virologically suppressed
HIV-infected individuals. In preliminary studies, MMP-13 can efficiently cleaves PNN components.
Published work has linked MMP-13 expression to HIV infection, and also shown reduced PNN
integrity in the background HIV associated cognitive dysfunction (HAND). Importantly, however, causes
and potentially critical neurophysiological consequences of PNN disruption in the setting of HAND have not
been well examined. In the present application, we plan to test the hypothesis that HIV relevant stimuli
including Tat can stimulate MMP-dependent PNN processing in vitro and in vivo, with consequent effects
on hippocampal PV activity, neuronal population dynamics and memory consolidation. !

Public health relevance
Narrative Cognitive dysfunction in HIV infected individuals continues in the era of combined antiretroviral treatment, suggesting that adjunct therapeutics targeting this issue are desperately needed. To determine which adjuncts may be most effective, a better understanding of the molecular mechanisms underlying altered neuronal activity in affected individuals is required.